The Physiologic Assessment of Exercise Capacity in Pediatric Sickle Cell Anemia

DESCRIPTION (provided by applicant): This application describes a set of proposed studies and structured career development plan carefully crafted to assist the Principal Investigator acquire the skills and experience necessary for becoming an independent clinical investigator in the areas of sickle cell anemia (SCA) and exercise physiology. Under the guidance of a group of accomplished mentors and scientific advisors, the Principal Investigator will gain additional formal training in patient-oriented research methodology, biostatistics, cardiopulmonary disease and applied exercise physiology. The practical and classroom training proposed will occur at the Northwestern University Feinberg School of Medicine and the University of Illinois at Chicago, both highly regarded institutions with extensive track records for the development of young physician-scientists. The Principal Investigator is currently an Assistant Professor of Pediatrics at Northwestern and an Attending Physician in the Division of Hematology, Oncology & Stem Cell Transplant at Children's Memorial Hospital. The overall objective of this study is to use cardiopulmonary exercise testing to delineate the pathophysiologic mechanisms that contribute to the impaired exercise response and reduced exercise capacity observed in children and young adults suffering from SCA. Although cardiopulmonary disease and the acute inflammatory response to exercise may contribute to exercise limitation in the general population, their role in reducing exercise capacity in children with SCA has not been systematically addressed. The Specific Aims of this proposal are to: 1) Evaluate peak oxygen consumption (VO2) and other aerobic parameters of the cardiopulmonary response to exercise obtained from gas exchange analysis in children and young adults with SCA undergoing cardiopulmonary exercise testing; 2) Characterize the acute inflammatory response to exercise, as measured by an increase in soluble vascular cell adhesion molecule (sVCAM) activity, in subjects undergoing cardiopulmonary exercise testing; and 3) Assess the longitudinal change in exercise capacity, as measured by peak VO2 on cardiopulmonary exercise testing, over a 2-year period in children and young adults with SCA. The paucity of data regarding the risks and benefits of exercise in children with SCA has contributed to the inability to develop recommendations for physical activity in this population despite the general consensus that regular exercise is beneficial for children who are both healthy and have a chronic medical condition. If achieved, the Specific Aims outlined in this proposal will yield critical data that will allow the Principal Investigator to develop evidence-based, exercise prescription programs aimed at improving physical functioning, exercise capacity and overall quality of life in children with SCA. Along with the mentoring and additional training gained from his proposed career development plan, the Principal Investigator will also be in the unique position to build upon these experiences as the basis for achieving future research independence.

Public health relevance
PROJECT NARRATIVE Although the burden of disease on physical functioning is tremendous in children suffering from sickle cell anemia (SCA), the underlying physiologic problems that contribute to reduced exercise capacity in this population are unclear and have not been systematically examined. Characterizing how the heart and lungs respond to exercise and how exercise causes inflammation are important steps to determining the risks and benefits associated with regular exercise in children with SCA. The information gathered from these studies will allow us to develop for the first time evidence-based, exercise prescription programs aimed at improving physical fitness, physical functioning and overall quality of life in children with SCA. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS Sickle cell anemia (SCA) is the most common single gene disorder in the US. There are an estimated 80,000 people in the US, primarily of African or Afro Caribbean descent, suffering from SCA, and the burden of disease, especially on physical functioning, is significant 1, 2. The physiologic basis for poorer physical functioning in children with SCA 3 is not well understood. Understanding exercise capacity in SCA is essential because poor physical fitness, as measured by exercise capacity, is the most important predictor of early morbidity and all cause mortality in the general population 4, 5. Cardiopulmonary disease and the acute inflammatory response to exercise are commonly cited contributors to decreased exercise capacity 6-8. The impact of these factors and their role in limiting exercise capacity among individuals with SCA, however, has not been systematically addressed. The purpose of this proposal is to 1) use cardiopulmonary exercise testing to delineate the pathophysiologic mechanisms responsible for poor exercise capacity among children and young adults with SCA, and 2) examine the longitudinal changes associated with exercise capacity in this population. The following hypotheses and aims are proposed: Hypothesis 1: In children with SCA, exercise capacity is significantly lower in subjects with abnormal cardiac and ventilatory responses to exercise on cardiopulmonary exercise testing, compared to subjects with normal cardiac and ventilatory responses. Specific Aim 1: Evaluate peak oxygen consumption (VO2) and other aerobic parameters of the cardiopulmonary response to exercise obtained from gas exchange analysis in children and young adults with SCA undergoing cardiopulmonary exercise testing. We will perform a prospective study of cardiopulmonary exercise testing, using a graded, maximal cycle ergometry protocol with gas exchange analysis, in 60 subjects with SCA and 30 controls without SCA. We will compare peak VO2 in subjects with and without an abnormal cardiopulmonary response to exercise, as determined by an integrated assessment of the dynamic variables measured from breath-by-breath analysis of gas exchange that reflect overall circulatory and ventilatory efficiency during exercise testing. In a secondary analysis, we will evaluate the relationship between baseline exercise capacity and disease morbidity by prospectively examining the frequency of SCA-related hospitalizations over a 24-month period. Hypothesis 2: Children with SCA and a severe decrease in exercise capacity demonstrate a significantly greater acute inflammatory response to exercise, compared to subjects with SCA and a mild to moderate decrease in exercise capacity. Specific Aim 2: Characterize the acute inflammatory response to exercise, as measured by an increase in soluble vascular cell adhesion molecule (sVCAM) activity, in subjects undergoing cardiopulmonary exercise testing. We will study the kinetic profile associated with the sVCAM response to exercise in all 60 subjects and 30 controls and compare the acute phase response in subjects with a severe decrease in exercise capacity to that in subjects with only mild to moderate decrease in baseline exercise capacity. The kinetic profiles of other biomarkers, including interleukin 6 (IL-6), interleukin 8 (IL-8), C-reactive protein (CRP), and D-dimer activity, also will be examined. In a secondary analysis, the relationship between inflammatory response and the development of pain in the immediate post-exercise period will be examined. Hypothesis 3: Children with SCA and a severe decrease in exercise capacity exhibit greater declines in cardiopulmonary fitness over time, compared to subjects with SCA and a mild to moderate decrease in exercise capacity. Specific Aim 3: Assess the longitudinal change in exercise capacity, as measured by peak VO2 on cardiopulmonary exercise testing, over a 2-year period in children and young adults with SCA. We will repeat exercise testing in all 60 subjects and 30 controls after a 2-year period and compare changes in peak VO2 in subjects with a severe decrease in exercise capacity to results in subjects with only a mild to moderate decrease on initial evaluation. In a secondary analysis, we will evaluate the relationship between 2-year change in exercise capacity and frequency of SCA-related hospitalizations over the previous 24-month period. We expect to demonstrate that in pediatric SCA, exercise limitation is frequently associated with an abnormal cardiopulmonary response to exercise and a heightened inflammatory response. This project addresses several important, fundamental knowledge gaps pertaining to exercise physiology in SCA. Through data generated from the proposed studies, the principal investigator will establish exercise capacity as a more clinically relevant, physiologically-based measure of physical functioning among individuals with SCA and develop novel, evidence-based strategies for improving physical functioning in this population.